A multilevel examination of attention in social anxiety disorder

PROJECT SUMMARY/ABSTRACT
Social anxiety disorder (SAD) is one of the most prevalent psychiatric conditions worldwide, with a
lifetime prevalence of 12.1%. SAD is associated with immense societal burden, including poorer educational
and occupational outcomes and reduced quality of life. A sizeable subset of SAD patients (~1/6) do not
respond to evidence-based treatments, and even more (17-60%) experience relapse following effective
treatment. Accordingly, there is a pressing need to identify novel mechanisms that may be effectively targeted
in treatment to improve patient outcomes.
Biases in the attentional system may hold promise for future translational work. Attentional bias (AB)
describes the preferential allocation of attentional resources to certain types of stimuli over others. In SAD, an
AB to external, social-evaluative threats (i.e., angry/disgusted faces) has been reliably observed in the
laboratory. However, interventions targeting this bias do not meaningfully reduce SAD symptoms, suggesting
that ABs to external threats may represent a disease correlate, not cause. A more meaningful form of AB in
SAD may be the extent to which individuals attend internally vs. externally in social situations. Indeed,
excessive internally focused attention (i.e., on one’s anxiety-laden thoughts, emotions, and interoceptive
sensations) is reliably linked to SAD severity and may contribute to disorder maintenance by increasing
perceptions of threat and thus triggering anxious responding across multiple levels. However, researchers
have not yet identified if, how, and for whom excessive internally focused attention plays a causal role in SAD
maintenance, which is essential to know to inform optimized interventions.
The proposed research will utilize an ecological momentary assessment-delivered experimental
manipulation to compare the role of internally vs. externally focused attention in the maintenance of SAD.
Outcomes will be explored longitudinally across self-report, behavioral, and cognitive levels of analysis, and
mechanisms (i.e., threat detection, state anxiety) and moderators (i.e., attentional control) of the effects will be
tested. The overarching goal of this project is to identify patterns of attention that play a causal role in the
maintenance of SAD to inform novel treatment targets. Specific training goals include conducting experimental
psychopathology research from an RDoC-informed framework, acquiring a deeper knowledge of the theory,
assessment, and modeling of cognitive systems, applying advanced quantitative methods, and developing
professional skills needed for a successful career in clinical science. By integrating theory and methods from
multiple areas of basic and clinical science, the PI will acquire a strong foundation for building an impactful
program of translational research that investigates the role of cognitive systems in the maintenance of anxiety
disorders.

Public health relevance
PROJECT NARRATIVE This project examines the role of the attentional system in the maintenance of social anxiety disorder. By leveraging an experimental design, ecological momentary assessment, and the multi-method measurement of outcomes across cognitive, behavioral, and subjective levels of analysis, this project aims to delineate how internally biased attention may causally contribute to social anxiety. A better understanding of what patterns of attention underlie disorder maintenance, the mechanisms that explain how biased attention causes ongoing anxiety, and the moderators that magnify or attenuate this effect has important implications for informing novel, effective treatments for social anxiety disorder and similar translational work in other internalizing disorders.